Strengthening capacity for policy-relevant life course epidemiological research in Ghana

Project Summary/Abstract
Forty-one million people die every year from non-communicable diseases (NCDs), accounting for
71% of all global deaths. Premature deaths, defined as deaths occurring in persons aged 30-69
years, disproportionately impact low- and middle- income countries (LMICs) like Ghana.
There is
an urgent need to develop a sustainable pipeline of interdisciplinary African physician scientists
(MD, MD/MS, MD/PhD) and postdoctoral investigators (PhD) dedicated to developing and
implementing evidence-based interventions to address the growing NCD burden in Ghana and
other West African countries. Our D43 takes a life course approach and is centered on the
principle that environmental exposures drive development of chronic disease and transitions from
health to disease begin in early life. Once risk factors develop, environmental exposures may
accelerate progression to disease and death. We propose to leverage four extant, well-
characterized cohorts (GRAPHS, PRISMA, KHP, and KHDSS) with extensive exposure
repositories to provide mentored research opportunities to examine how environmental
exposures: i) set in motion aberrant developmental trajectories; ii) accelerate progression to
disease once risk factors are established; and iii) are associated with mortality. Ghanaian trainees
will be enrolled in three tracks – PhD training, Master degree training, and short-term workshops.
Training will be led by the Kintampo Health Research Centre, one of three Government of Ghana
research centers and a part of Ghana’s Ministry of Health therefore providing a direct linkage from
research to policy. KHRC will be joined by the University of Ghana’s School of Public Health, a
premier Master and PhD degree-granting institution in Ghana and where coursework will occur,
and Columbia University and the Icahn School of Medicine at Mount Sinai. Additionally, we will
develop seminar series and a grant writing workshop and provide grant administration support to
build research infrastructure in Ghana and support professional advancement of D43 trainees.

Public health relevance
Project Narrative Forty-one million people die every year from non-communicable diseases (NCDs), accounting for 71% of all global deaths and premature deaths, defined as deaths occurring in persons aged 30-69 years, disproportionately impact low- and middle- income countries (LMICs) like Ghana. There is an urgent need to sustainably build NCD expertise in Ghana for cardiovascular, metabolic and pulmonary disease, with the ultimate goal of training experts who will generate research evidence that can advance public health policy and improve public health. The goal of this training program with experienced faculty from the Kintampo Health Research Centre and University of Ghana School of Public Health and US-partners at Columbia University and Icahn School of Medicine at Mount Sinai is to provide mentored life course NCD and environmental epidemiology training to Ghanaian researchers.